Hazardous Materials Worker Health and Safety Training

The New Jersey / New York Hazardous Materials Worker Training Center will provide training for essential works to respond and work safely when faced with exposure to COVID-19. The Center will provide train-the-trainer course via distance web conferencing to expand the knowledge of trainers to provide the NIEHS developed COVID-19 training tools. Rutgers will provide the training for instructors at Make the Road New York and Wind of the Spirit. These instructors will then provide training for essential workers in the communities. Rutgers will partially fund MDB, Inc. to develop multi-step process to locate, organize, visualize, and present the critical information for workers. NYU School of Global Public Health (NYUGPH) will develop and launch online, interactive, mini-lessons geared around the recognition, evaluation, and control of infectious disease agents. NYUGPH proposes to develop 3 interactive lessons within each of the 3 modules (recognition, evaluation and control) for a total of 9 interactive lessons. World Cares Center (WCC) will deliver worker-based training to prevent and reduce the exposure of hospital employees, first responders, disaster volunteers and others who are at risk of exposure to SARS-CoV-2 through their work duties. NYCOSH will provide a 7-hour Infectious Disease and Industrial Hygiene Train the Trainer course for seven NYCOSH staff who regularly train other workers. The Center will train approximately 937 workers through this project.

Public health relevance
The NJ/NY Hazardous Materials Worker Training Center will support essential workers in their response to the COVID-19 pandemic. The public health impact of training provided by the Center will prevent and reduce injuries and illness due to potential risks posed by infectious diseases. Training provided is the vital to educating workers in safety and health issues.